Selenium metabolism in cold-induced adaptive thermogenesis

ABSTRACT
The studies proposed in this Administrative Supplement to parent grant DK128390 aim to promote the scientific
research and career development of Sydonie Swanson, a Postbaccalaureate candidate with a Hispanic heritage
seeking to gain research experience. The parent grant focuses on determining the role of selenium recycling in
regulating selenoprotein enzymes GPX1 and DIO2 in brown adipose tissue and how the recycling mechanism
contributes to cold-induced adaptive thermogenesis in vivo, using whole-body and brown adipocyte-specific
knockout mouse models of the selenium recycling enzyme selenocysteine lyase (SCLY). This Administrative
Supplement will complement these studies by pursuing these Research Aims: 1) To determine the role of
selenium and SCLY in the differentiation of brown adipocytes; and 2) To determine if treatment of pre-adipocytes
with selenium or the activity of SCLY controls the expression and activity of selenoprotein GPX4, impacting
responses to ferroptosis,
an iron-dependent cell death mechanism, in differentiated brown adipocytes. The
Research and Career Development Plan for Sydonie focuses on training technical (e.g., histology, microscopy,
gene editing, bioinformatics) and professional (e.g., experimental design, scientific writing, and oral
presentations) skills in a collaborative environment that will provide a robust research experience and favor her
successful inclusion in the medical workforce.

Public health relevance
PROJECT NARRATIVE This Research Supplement application to a parent R01 will provide one Postbaccalaureate Candidate from an underrepresented minority an opportunity to pursue a Research and Training Plan, contributing to increasing diversity in the scientific workforce. The Research Plan component aims to investigate: a) the role of the micronutrient selenium and its recycling in brown adipocyte differentiation, and b) if selenium contributes to the responses to ferroptosis, an iron-dependent cell death mechanism, in differentiated brown adipocytes. The Training Plan component details career development activities, such as specialized courses, workshops and meetings, geared for the Applicant's career short-term progress toward a successful application to a Postbaccalaureate Program, and long-term contribution to a diverse medical workforce and an MD/PhD.